Mechanisms of Metabolic Dysregulation in ZZ Alpha-1 Antitrypsin Deficiency Associated Liver Disease

This proposal details a 5-year career development training program focused on studying the basic mechanistic
underpinnings of alpha-1 antitrypsin deficiency (AATD) associated liver disease with the goal of developing new
treatments for these patients while simultaneously providing the necessary training required for Dr. Kaserman to
become a future independent investigator. Individuals homozygous for the “Z” mutation, the most common liver
disease-causing variant in AATD, accumulate polymerized Z alpha-1 antitrypsin (ZAAT) protein within the
endoplasmic reticulum of hepatocytes resulting in cellular injury. Patient induced pluripotent stem cell (iPSC)-
hepatocytes (iHeps) derived from ZZ individuals have recently been shown to exhibit dysregulated metabolic
function as well as branch-specific activation of the unfolded protein response (UPR) among distinct hepatocyte
subsets. Activation of the UPR, comprising three distinct signaling pathways (ATF6, PERK and IRE1), has been
shown to induce hepatic steatosis and fibrosis in multiple other causes of liver disease, and the activation of
PERK within ZZ iHep subsets was associated with a pro-fibrotic/ER stress transcriptomic profile while activation
of ATF6 was associated with preservation of a homeostatic metabolic transcriptional profile. These observations
have informed this proposal’s central hypothesis that the branch specific activation of ATF6 signaling in ZZ
hepatocyte subsets preserves homeostatic metabolic function through increased metabolic transcription factor
expression, oxidative phosphorylation, and an associated reduction in steatosis. This hypothesis will be tested
in three specific aims: 1) Test whether ATF6 activation observed in sorted ZZ iHeps is associated with increased
metabolic function and reduced steatosis relative to ATF6 low iHeps. 2) Directly test the contributions of ATF6
and PERK activation to ZZ protein accumulation, cellular homeostasis, and dysfunction through pathway
modulation. 3) Test the therapeutic potential of novel drug candidates to ameliorate AATD-associated metabolic
dysfunction in-vitro and in-vivo. The scientific component of this proposal is accompanied by a detailed training
program that combines expert mentorship, selected coursework, and new analytical and technical expertise
focused on hepatocyte metabolism, CRISPR interference (CRISPRi) gene modulation, and the “PiZ” mouse
model of AATD associated liver disease. The assembled Advisory Committee members have been carefully
chosen based on established track records for productivity and junior faculty mentorship. The mentorship team
headed by Dr. Andrew Wilson (primary mentor) and Dr. Anthony Hollenberg (co-mentor) have complementary
expertise in the areas of AATD, stem cell biology and metabolism making them ideally suited for this candidate’s
career development award. The mentorship team is further strengthened by the expertise of Dr. Wolfram
Goessling and Dr. Valerie Gouon-Evans, both experts in liver development, regeneration, and mouse models of
liver disease. At the completion of this proposal Dr. Kaserman will have developed the necessary expertise to
successfully transition into a career as an independent physician-scientist and future academic leader.

Public health relevance
Alpha-1 antitrypsin deficiency associated liver disease is a significant cause of morbidity and mortality with no specific treatments beyond organ transplant. This proposal intends to test the hypothesis that ATF6 branch signaling within a subset of hepatocytes preserves homeostatic hepatocyte metabolic function and has an associated reduction in steatosis. Through an advanced understanding of underlying disease mechanisms new potential druggable targets could be identified and represent novel future treatment options for patients with alpha-1 antitrypsin deficiency associated liver disease.